Kidney Disease Aging Research Collaborative (KDARC) Research Infrastructure to Advance the Science of Geriatric Nephrology

ABSTRACT
Kidney Disease Aging Research Collaborative (KDARC) will address a fundamental challenge in nephrology
by establishing infrastructure to support sustainable interdisciplinary research on the science of aging.
Although kidney disease occurs in ~40% of older (aged≥65 years) adults, among whom up to 70% are frail and
87% have cognitive impairment, adult nephrology care ascribes to a “one size fits all” approach ignoring
geriatric syndromes. As noted by the National Academies of Science, Engineering, and Medicine there is a
significant age disparity in accessing the preferred forms of kidney disease treatment. These age disparities
are driven by the dearth of research on kidney disease patients with geriatric syndromes. In contrast to the
18,200 general nephrology publications, only 183 geriatric nephrology manuscripts have been published since
2000. Consequently, there is wide variation in choice of geriatric tools in clinical practice and research.
Geriatric nephrology research is limited by 3 major barriers: 1) organizational barriers that dissuade
interinstitutional collaborations, 2) data barriers that leave pressing research questions unanswered, and 3)
workforce development barriers that limit entry into the field, especially for underrepresented in medicine
(URIM) faculty. To advance and sustain the science of aging in nephrology, novel research infrastructure that
address these barriers and supports faculty who are URIM, early career, and/or new to aging research are
critically needed. Therefore, we have taken the first steps to establish a new geriatric nephrology research
collaborative, KDARC and identified 3 geriatric nephrology research priorities. We will establish a robust and
sustainable infrastructure in KDARC through a Development Phase (R61) and Application Phase (R33);
progress will be guided by an experienced Oversight Board and monitored by yearly milestones. R61 Specific
Aims, Development Phase: 1. Formalize KDARC organizational structure and procedures (Year 1-2); 2.
Convene a consensus conference on geriatric nephrology research priorities (Year 2); and 3. Establish
KDARC Data Cooperative with existing data (Years 1-2). R33 Specific Aims, Application Phase: 1. Enable
KDARC investigators to launch new geriatric nephrology studies (Year 3); 2. Support geriatric nephrology pilot
studies (Year 3-4); and 3. Advance geriatric nephrology research skills (Year 3-5). KDARC will establish the
necessary research infrastructure to stimulate new interdisciplinary research in aging and kidney disease by
leveraging existing datasets, formalizing new data collection for preliminary data, and investing in the career
development of its members. KDARC resources will be widely available to the broader research community.
Ultimately, KDARC will produce critically needed high-impact and high-priority geriatric nephrology research
that will reduce well-recognized age disparities in nephrology and positively impact the lives of the 22.4 million
older adults living with kidney disease in the US.

Public health relevance
PROJECT NARRATIVE The Kidney Disease Aging Research Collaborative (KDARC) will address a fundamental challenge in nephrology by establishing sustainable research infrastructure that will facilitate collaborations, clarify research priorities, minimize barriers to data access, and enhance investigator development. Ultimately, this infrastructure will enable high-impact research on the science of aging in nephrology and improve the health and well-being of 22.4 million older adults who are living with kidney disease in the US.